Artificial intelligence Optical Coherence Tomography Guided Deep Anterior Lamellar Keratoplasty (AUTO-DALK)

PROJECT SUMMARY
Contemporary ocular surgeries are performed by skilled surgeons through operating microscopes,
utilizing freehand techniques and manually operated precision micro-instruments, where the outcomes are often
limited by the surgeon's skill levels and experiences. To overcome these human factors, we have assembled
an interdisciplinary team including a clinician-scientist and eye surgeon, an optical device scientist and medical
robotic engineers to translate existing and developing technologies in our laboratories into precision, “deep-
learning” artificial intelligence (AI) guided robotic ocular surgical devices for precise automated Deep Anterior
Lamellar Keratoplasty (AUTO-DALK).
DALK is a highly attractive treatment of corneal disease with normally functioning endothelium. However,
the procedure is unusually challenging from a technical perspective and time-consuming, limiting its acceptance
among corneal surgeons. The most challenging aspect of the procedure is related to the delamination of stroma
from Descemet's membrane (DM). A procedure, commonly called “Big Bubble” is used to separate stroma from
DM using deep intrastromal pneumatic injection. However, even experienced surgeons have difficulty precisely
placing the injection. The most common complication of DALK is the excessive depth of the needle insertion
resulting in Descemet's membrane perforation requiring conversion to full-thickness penetrating keratoplasty
with its much longer recovery period and a higher risk of graft failure from rejection. The reported rates of
Descemet's membrane perforation for beginner and experienced surgeons are 31.8% and 11.7% respectively.
In addition, interface haze between the donor and recipient cornea is a common problem caused by the
insufficient depth of needle insertion and failure to remove the host stromal tissue, which results in loss of
postoperative visual acuity. These problems relate directly to the inability of the current surgical practice to
precisely assess the depth of the tooltips inside the cornea layer in real-time.
Here we will build upon our previous and ongoing work in robust fiber optic common-path optical
coherence tomography (CP-OCT) and AI-guide system based on convolutional neural network (CNN) robotic
microsurgical tools that enable clinicians to precisely guide surgical tools at micron scale. The proposed AUTO-
DALK surgical tool system is capable of one-dimensional real-time depth tracking, motion compensation, and
detection of early instrument contact with tissue, which enables clinicians to perform DALK precisely and safely.
The tool will be built on a handheld platform that will consist of CP-OCT probe, trephine and microinjector that
allows precise and safe removal of the anterior section of cornea down to DM
We hypothesize that AI-OCT providing intelligent visualization and depth controlled optimal cornea
cutting and tissue tracking will perform the task of DALK with better accuracy and efficiency over the manually
performed trephine cutting and “Big Bubble” pneumodissection.

Public health relevance
Project Narrative This proposal addresses fundamental limitations in current corneal transplant surgery by developing an artificial intelligence guided compact robotic surgical tool that could empower corneal surgeons to achieve difficult surgical objectives, reduce intraoperative complications, and improve clinical outcomes when performing Deep Anterior Lamellar Keratoplasty (DALK). Further, these capabilities are broadly applicable in other microsurgical problems, and the tools will enable further advances both for ophthalmology and for other microsurgical disciplines.